Computational methods for delineating subcellular and cellular spatial transcriptional heterogeneity along developmental trajectories

Project Summary
Biological differences between cells in healthy and diseased states are molecularly encoded in part
by coordinated differences in gene expression. Gene expression differences between healthy and disease
cell states may manifest as altered expression magnitudes of important regulatory factors, as well as
aberrant alternative splicing of genes to produce protein isoforms with divergent functions. Likewise, the
spatial localization of mRNAs within cells play important regulatory roles in modulating local protein
translation that may be disrupted in disease. And finally, cells exist within diverse microenvironments
where they signal and interact with different cells to maintain homeostasis within tissues. Quantitatively
evaluating these different aspects of transcriptional heterogeneity between cells in healthy and diseased
states is paramount to our understanding of disease etiology and the mechanisms for disease pathogenesis.
Recent advancements in next-generation sequencing and imaging technologies are enabling
investigators to quantitatively measure gene expression in individual cells at transcriptome-scale across
different biological and disease settings in a high-throughput manner. As such, the ability to perform
computational analysis is becoming increasingly paramount in order to extract biological insights from such
data. My research program develops statistical approaches and computational tools to identify and
characterize these aspects of transcriptional and spatial heterogeneity and quantitatively evaluate the
functional consequences of this variation.
Here, we will focus on developing computational tools to delineate 1) transcriptional heterogeneity
across populations of cells, 2) subcellular spatial transcriptional heterogeneity within cells, and 3) spatial-
contextual heterogeneity among cells in tissues. Specifically, I will build on my previous experience
developing statistical approaches for unified clustering analysis in order to identify the appropriate normal
cells for comparison with cells from transcriptionally heterogeneous diseased states. I will further build on
my previous experience detecting alternative splicing to characterize aberrant alternative splicing within
individual cells and assess how such alternative splicing may impact cellular function through subcellular
localization. I will further assess how mRNA localization patterns may change through dynamic processes
such as the cell-cycle and neuroglia maturation within tissues to impact cell-fate. Finally, I will assess how
the spatial-contextual organization of cells within tissues may impact cell-cell communication networks.
Although we focus on establishing proof of concept in model systems, pursuit of these research goals will
result in the development of new computational methods available as open-source software that can be
tailored and applied to address fundamental biological questions in a variety of disease settings.

Public health relevance
Project Narrative A more thorough quantitative evaluation of the transcriptional differences between cells in healthy and diseased states particularly is paramount to our understanding of disease etiology. This includes analyzing the transcriptional differences between diseased cells and appropriate normal counterparts both in terms of gene expression and alternative splicing, as well as potential mRNA subcellular localization differences and cellular spatial-contextual differences within tissues. This proposed work will develop computational tools to enable such analysis using large-scale single-cell RNA-sequencing and spatially resolved transcriptome imaging data.